CLINICAL RESEARCH TRAINING IN PSYCHIATRY

This application is a competitive renewal of 5 T32 MH16804-15, "Clinical Research Training in Psychiatry," a postdoctoral training program for post- residency psychiatrists and Ph.D.s in the behavioral sciences. The overarching goal of this training program is to develop outstanding clinical researchers in psychiatry. Now in its 15th year, this program takes advantage of an outstanding training environment at the Department of psychiatry and Western Psychiatric Institute and Clinic, at the University of Pittsburgh School of Medicine. The Department of psychiatry has a longstanding commitment to clinical research training, and provides fellows with a rich clinical and research infrastructure, including a broad range of patient populations. The Department has a wide range of NIH-funded Clinical Research Centers, and the vast majority of our program faculty are engaged in multidisciplinary research as leading basic and clinical scientists. The program has several fundamental training components. The most important is an apprenticeship with an academically successful mentor from our program faculty, who represent numerous areas of expertise in psychiatry and neuroscience. Fellows work with mentors on ongoing projects and develop new investigations. In conjunction with the mentor, fellows write data-based and review papers for publication in peer-reviewed journals. During the second year of training, fellows develop and submit an NIH career development or research grant proposal to provide the transition to the status of an independent investigator. Another training component is the development core knowledge in psychobiology research design, statistics, assessment in adult and geriatric psychopathology. Individually-prescribed coursework and didactic study are assigned to each trainee based on their specific needs. Trainees also develop coarse skills and knowledge in grant writing and project management by participating in a weekly fellowship seminar on "research survival skills." Finally, trainees develop core knowledge of ethical issues in research, via specialized seminars and assigned readings. This postdoctoral training program has achieve considerable success since its inception in 1981, and during the current funding period (1991- present). The large majority of fellows who have completed the program have obtained high-quality academic positions and become productive independent researchers in psychiatry. Based on this program' s successful past record, recent significant increases in our research training capacity and the number of qualified applicants, this competitive renewal requests support for five post-doctoral trainees in each of Years 16-20. We believe that we will continue to be well positioned to help address the critical shortage of career clinical investigators in psychiatry.